Carboxylesterase 1 Genetic Variation and Methylphenidate in ADHD

Attention-deficit/hyperactivity disorder (ADHD) is the most common neuropsychiatric disorder of
childhood in the US. As of 2011, approximately 6.4 million children between the ages of 4 and
17 years of age have received a diagnosis of ADHD. Of these individuals, approximately 60%
will be prescribed medication and the psychostimulant d,l-methylphenidate (MPH). In 2010,
MPH was the most frequently prescribed medication of any type in adolescents aged 12-17 yrs.
There is significant variability between individual patients in terms of blood concentrations
measured (i.e. pharmacokinetics [PK]), clinical response, and adverse effects in individuals on
the same dosage. Some severe adverse drug reactions (ADRs)-including sudden cardiac
death--have been associated with MPH, although the precise reasons for these associations
remain controversial. Up to 35% of AHDH patients do not respond satisfactorily to MPH therapy.
Presently, there is no specific test or biomarker predictive of who will have a positive or negative
response to or adverse effects from MPH treatment. The major hepatic enzyme
carboxylesterase 1 (CES1) is responsible for MPH metabolism/deactivation. This project
proposes to further identify and characterize genetic variants that affect CES1
expression and activity and reveal key associations between CES1 genotypes and the PK and
pharmacodynamics (PD) of MPH in ADHD patients.
This project will produce clinically relevant data, with great potential to improve the safety and
clinical efficacy of MPH treatment in tens of thousands of patients annually. Study results can
quickly be translated and adapted to clinical use in evidence-based strategies applied
to drug selection and dosing in patients with ADHD and those medicated with other CES1
substrates.

Public health relevance
Methylphenidate ([MPH] Ritalin®, Concerta®, others) is one of the most commonly prescribed psychostimulant medications for ADHD. However, clinical outcomes of MPH pharmacotherapy can vary significantly among patients and there are presently no known reliable biomarkers or predictors of drug response, tolerability, adverse events, or efficacy. This comprehensive proposal is directed at the study of the impact of genetic variation of the gene CES1 which encodes for carboxylesterase 1 (CES1), the primary enzyme responsible for metabolizing /deactivating MPH. Furthermore, the influence of CES1 variants in conjunction with a number of other genes which have been variably related to the PD effects of MPH will also be assessed which may impact overall therapeutic outcome in ADHD patients. The project incorporates both novel basic science and clinical investigative approaches that hold enormous potential to improve the efficacy and safety of MPH through drug regimen individualization. The project also has implications for a host of other CES1 substrate medications used in children and adults alike.